University of Washington Interdisciplinary Center for Exposures, Diseases, Genomics & Environment

ABSTRACT The theme of the UW Interdisciplinary Center for Exposures, Diseases, Genomics and Environment (EDGE Center) is Biochemical and Molecular Mechanisms Underlying Human Variability in Response to Environmental Exposures. We envision a future in which world-class EHS research informs policy and practice to significantly reduce the burden of environmentally related diseases. The purpose of this NIEHS Core Center is to provide the administrative infrastructure and technical support necessary to foster multidisciplinary collaborations that will extend basic mechanistic studies on environmental health problems to direct applications in human populations. The EDGE Center will continue to have an emphasis on “gene x environment” interactions, with an increased emphasis on development and integration of EHS for public health decision-making. This Center consists of 59 Environmental Health Sciences (EHS) Core investigators and 35 other investigators involved in Clinical and Translational Sciences (CTS) research at the UW, organized into 5 disease-based Collaborative Research Teams (CRTs): 1) Environment & Cancer; 2) Developmental & Reproductive Disorders; 3) Neurodegenerative Diseases; 4) Cardiopulmonary & Metabolic Diseases; and 5) Hepatic, Renal & Gastrointestinal Diseases. The outstanding research of UW EHS Core faculty is enhanced by 3 Facility Cores. 1) The Integrative Environmental Health Sciences Facility Core fosters clinical and translational population-based research and disaster research response activities. 2) The Genomics, Bioinformatics & Biostatistics and Microphysiological Systems Core enables Center members to utilize OMICs technologies and provides rigorous analysis of the data. It also provides access to in vitro systems that mimic complex tissue architecture suitable for investigating organ-like physiology in the context of toxicological perturbations. 3) The Exposure Assessment, Biomarkers & Environmental Sensing Core offers state-of-the-art exposure assessment tools and approaches. In addition, the Center supports exploratory research projects into innovative new ideas related to the theme of the Center each year through a Pilot Projects Program as well as mini-pilot grants throughout the year. The Community Engagement Core provides a mechanism to connect Center investigators, community partners, and other stakeholders in productive bi-directional EHS-focused dialogue and activities. The resources available through the EDGE Center have assisted members in achieving their fullest potential as EHS investigators. Center involvement has resulted in numerous publications, research grants, and training opportunities. Of the 94 current EDGE members, 37 are Principal Investigators on 65 grants that will be active as of May 31, 2021. The total annual direct costs for these grants are slightly over $36 M, of which approximately 83% ($30 M) is from NIH. EDGE faculty members are PIs on 11 current NIEHS grants that will still be active as of May 31, 2021.

Public health relevance
PROJECT NARRATIVE The Center for Exposures, Diseases, Genomics, and Environment (EDGE) fosters novel research on molecular signatures associated with toxicant exposures using modern molecular and systems biology approaches to explain interactions between genetic, epigenetic and environmental factors and how these contribute to both acute and chronic diseases of public health importance. The EDGE Center is dedicated to contributing to evidence-based changes in regulatory policy and public health or medical practice that result in a reduction in the burden of environmentally related diseases.